Computer vision powered automation of rodent arena for assessment of early Alzheimer's disease.

Project summary
Alzheimer's disease (AD) is the most common cause of age-related neurodegenerative disease and dementia.
Despite its prevalence and deliberating health consequence, early diagnosis of AD is a serious unmet need.
The current proposal seeks to develop a behavior biomarker that differentiates AD from a normal ageing
process.
The project proposes to develop an automated rodent behavior testing system for non-invasively assessing the
early AD, based on strong evidence from AD imaging studies and neurophysiology research on a specific type
of innate defensive behavior across a variety of species.
The midbrain structure governing the sensorimotor computation of looming stimuli can trigger defensive
behaviors, such as freezing and escape, in rodents. Interestingly, a number of clinical studies have shown that
the midbrain region is affected very early in AD. Taking the findings from the two areas together, it is
conceivable that the defensive behaviors triggered by looming stimuli can serve as a biomarker for early AD.
MPI Drs. Chen and Luo’s preliminary study with AD mice has provided a proof of concept. In this SBIR grant,
we propose to develop an automated defensive behavior testing system, and conduct rigorous studies to show
the association between AD pathology and defensive behaviors. We believe the system can help accelerate
AD research, by providing a novel assessment of early AD and saving cost.

Public health relevance
Narrative To support earlier and more accurate diagnosis of Alzheimer’s Disease, this application proposes to develop an automated system to assess early AD non-invasively, by testing innate defensive behavior in rodents. This objective addresses the PAS-22-196 “Advancing Research on Alzheimer's Disease (AD) and AD-Related Dementias”. A predictive biomarker for AD will support an earlier and accurate diagnosis of the disease to ensure appropriate care and advance clinical research.